Using complex video stimuli to elucidate atypical brain functioning in ASD

SUMMARY: The discovery and reﬁnement of brain-based signatures of autism spectrum disorder (ASD) has
for many years been a highly desired, but as yet elusive, goal. One key challenge identiﬁed has been that
numerous levels and sources of variability — between sites, between participants, and within participants —
obscure the search for these reproducible neural signatures, complicating the search for biomarkers and
undermining the elucidation of cognitive and neural mechanisms. In this renewal application we propose a
sequence of studies to dissociate and quantify these sources of variability. We will acquire a new fMRI dataset
that is partly continuous with data accrued during the prior funding period and has 3 key features. First, we
will scan participants with ASD and matched controls while they watch complex videos with rich narrative
content. Evoked responses to videos constrain variability within and across participants and data collection
sites, as borne out by strong pilot data, and naturalistic videos better approximate the demands of processing
complex real-world social situations. Second, we will use densely-sampled, longitudinally-acquired, high-
quality neuroimaging data that will permit precise, stable, and reliable measurements of an individual's brain
function. Third, we will collect primary data at two sites (Indiana University and Caltech) in order to ensure
broader generalizability. Using machine learning techniques, Aim 1 will learn where in the brain and when, in
response to the video, individuals with ASD diverge most from control participants. Extending beyond group-
level averages, we will also take a dimensional approach to link brain diﬀerences to phenotypic variation, and
a clustering approach to identify variation consistent with the presence of ASD subgroups. In Aim 2, we will
leverage these results together with state-of-the-art computer vision and speech algorithms to quantify the
stimulus features of the videos that evoke these neural diﬀerences, both at the level of the group and of the
individual, and examine their relationship to phenotypic diﬀerences. Our comprehensive feature
decomposition of the videos will query high-level semantic features, object-level features like faces, and low-
level perceptual features. Finally Aim 3 will share the all the products of this work — e.g., raw and processed
data, acquisition tools, annotations, analysis scripts — on OpenNeuro, NDA, and Github in modern formats
(e.g., using BIDS format, and with fMRIprep and MRIQC as processing and quality assurance tools) to make
them maximally accessible to others. Uniquely, this data release will be validated and reﬁned at yet a third
site, the University of Iowa, on a smaller sample of control participants. This renewal application will thus build
upon tools, data, and progress from the current funding period, and capitalize on state-of-the-art computer
vision and neuroimaging analysis methods to identify audiovisual stimulus features that evoke atypical neural
activity in individuals with ASD. This project will provide new insight into neural and cognitive diﬀerences in
ASD, and help guide future investigations toward neuroimaging-based markers.

Public health relevance
PROJECT NARRATIVE Autism spectrum disorder (ASD) is a neurodevelopmental condition that affects approximately 1% of the population, yet its neural and cognitive bases remain elusive. This proposal will use complex video stimuli together with functional neuroimaging (fMRI) and computational methods to identify brain regions that best predict ASD groups, subgroups, and traits, identify the underlying stimulus features that drive these neural differences, and make the data and tools we generate maximally available for others to use and build upon.